Task C06: Lung Microphysiological Systems as Models of Infectious Diseases for BSL-3 Pathogens

This contract provides for the development and standardization of nontraditional animal models of infectious diseases and may include candidate product efficacy testing, including GLP studies to support licensure.